STUDIES OF STREPTOCOCCAL SEQUEL

Our efforts here are two fold. 1) The long term follow-up of patients in our rheumatic fever clinic. 2) We have now produced a hybridoma antibody which will identify 100% of all rheumatic fever patients. The inheritance of the marker in rheumatics and their families is currently under investigation with the eventual goal of identifying the gene.